Regulation of C. difficile colitis by host genetic and immune factors

Project Summary:
Clostridium difficile is the leading nosocomial infection in the U.S. Host factors are a key predictor of disease
outcomes after C. difficile infection (CDI). We have discovered a key role for leptin receptor (LEPR) pathway and
the pro-inflammatory cytokine Macrophage Inhibitory Factor (MIF) in CDI pathogenesis. Our data reveal that a
common single nucleotide polymorphism (SNP) in the gene for LEPR (Q223R; present in up to 50% of humans)
is associated with exaggerated MIF production after CDI in humans. CDI in mice homozygous for the mutant
SNP (RR) resulted in higher MIF production, more colonic neutrophilia and tissue damage, without effects on
pathogen. We reported that neutralizing MIF using antibody resulted in reduced tissue injury and improved
survival in mice, without effects on C. difficile pathogen. Finally, blocking a key receptor for MIF, CXC chemokine
receptor 2 (CXCR2) also reduced CDI-induced neutrophil accrual in tissue. This proposal is based on these
published results and new preliminary data which indicate that LEPR Q to R change augments Bcl-2 like protein
11 (Bim) expression which controls MIF release by modulating pathways of autophagy/mitophagy/apoptosis.
The overall hypothesis of our studies is that: LEPR Q to R substitution exaggerates CDI-induced, Bim-dependent
MIF release that augments CXCR2-dependent tissue neutrophil accrual and worsens disease severity. To test
this hypothesis, we propose three specific aims. Aim 1 will define the key pathogen-associated drivers of MIF
and the main cellular sources of MIF production in CDI. We will use WT and toxin-deficient C. difficile strains to
determine the role of toxins and non-toxin factors in driving MIF expression. Cellular sources of MIF will be
defined after CDI in WT mice by intracellular staining and immunohistochemistry and their role in CDI will be
tested by using selective MIF deletion in intestinal epithelial cells and in hematopoietic cells. Aim 2 will examine
the mechanism of CDI-induced MIF release. We will determine the role of LEPR Q to R substitution in regulating
Bim expression and subsequent autophagy, mitophagy and apoptosis pathways. Studies will use Bim-reporter
and Bim-deficient mice, and Bim+/+ and Bim-/- human intestinal organoids generated from induced pluripotent
stem cells in both QQ and RR background. Aim 3 will investigate the role of MIF-CXCR2 axis in CDI-induced
tissue neutrophilia in QQ and RR mice. We will compare the effect of MIF on neutrophil trafficking and on their
lifespan. We will utilize neutrophils derived from WT and CXCR2-/- mice in in vitro (migration assays) and in vivo
(after depletion of endogenous neutrophils and reconstitution with labeled neutrophils prior to infection)
experiments. We expect these studies to provide a greater understanding of the role of host genetics in regulating
MIF during CDI pathogenesis. Our studies have the potential to identify new host-based targets that can be used
in the design of novel CDI therapies.

Public health relevance
Project Narrative: Clostridium difficile infections (CDI) have been categorized as one of the top 5 “urgent” public health threats by CDC. Host factors including genetics and immune mediators are key regulators of CDI pathogenesis. Here, we propose to investigate how a common mutation in the gene for leptin receptor affects CDI-induced inflammatory cytokine Macrophage Inhibitory Factor.